Role of Fibulin-1 in APP Processing

DESCRIPTION (provided by applicant): Many current pharmacological approaches to combating Alzheimer's disease (AD) seek to block Aβ production through inhibition of the amyloidogenic enzymes known as β- and γ-secretases. An alternative approach is to activate the α-secretase processing of amyloid precursor protein (APP), which is mediated by several members of the disintegrin family of metalloproteases, ADAM9, ADAM10 and ADAM17. Processing of APP by these α-secretases is thought to be beneficial with respect to AD since it limits production of Aβ and generates the neuroprotective soluble APPα (sAPPα) product. Fibulin-1 (Fbln1) is an extracellular matrix protein, expressed in the brain by neurons, that binds the amino terminus of APP and sAPPα. The significance of this interaction is not yet established however, we have found that Fbln1 also binds to other membrane anchored α-secretase substrates, heparin binding-epidermal growth factor (HB-EGF) and neuregulin-1 (NRG1). We also show that Fbln1 acts to inhibit the proteolytic release of soluble forms of HB-EGF and NRG1. Furthermore, we have found increased levels of sAPPα in the conditioned culture medium of Fbln1 null mouse embryo fibroblasts (MEFs) as compared to wildtype MEFs. Based on these findings it is hypothesized that Fbln1 serves as an inhibitor of α-secretase processing of APP and therefore may represent a therapeutic target that if inhibited might lead to augmented α-secretase processing of APP and reduced pathological APP cleavage. To address this hypothesis there are three specific aims: 1) Determine whether brain APP proteolytic cleavage is altered in Fbln1-deficient mice, 2) determine whether transgenic overexpression of Fbln1 accelerates Aβ production and exacerbates AD pathogenesis, and 3) determine whether Fbln1 inhibits α-secretase processing of APP in cultured cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: The overall goal of this project is to determine the role of fibulin-1 (Fbln1) in the pathogenic process of Alzheimer's disease (AD) and other neurodegenerative diseases. The experimentation will test the hypothesis that Fbln1 interacts with the amyloid precursor protein (APP) to regulate proteolytic processing events associated with AD. The experimentation will also determine if Fbln1 is a potential target for therapeutic intervention in AD.